Cannabidiol (CBD) as a Potential Therapeutic for Experimental Subarachnoid Hemorrhage

ABSTRACT
Subarachnoid hemorrhage (SAH), commonly caused by a ruptured aneurysm, carries a high rate of disability
and death. Preclinical studies demonstrate SAH induces dysregulation of the cerebrovasculature, which con-
tributes to early brain injury and delayed cerebral ischemia. Few treatment options currently exist for SAH
patients, making it imperative to identify novel therapies to improve outcomes following SAH. Cannabidiol
(CBD) has gained attention for its potential therapeutic properties and widespread mechanistic actions. First
utilized for the treatment of pain, preclinical studies demonstrate CBD has anti-inflammatory, neuroprotective,
and vascular stabilization properties in experimental models of injury. However, understanding of the effects
of CBD on blood vessels in the brain is limited, and no studies have directly investigated CBD as a treatment
for SAH, representing critical gaps in knowledge. The overall objectives of this application are to determine
the therapeutic potential of CBD for SAH injury and identify processes by which CBD improves vascular
health. The central hypothesis is that daily CBD treatment improves vascular integrity to increase cerebral
blood flow (CBF) and prevent DCI, thereby improving functional outcomes and mortality following SAH. The
rationale for this project is that determination of CBD’s therapeutic efficacy in SAH will generate a strong
scientific framework from which new strategies for SAH therapy can be developed. The central hypothesis
will be tested by pursuing two specific aims: 1) Determine CBD’s efficacy to improve functional outcomes and
mortality following SAH, and 2) Identify the impact of CBD therapy on cerebral microvessel pathology follow-
ing SAH. Under the first aim, multiple doses of CBD will be tested in mice following SAH injury (endovascular
perforation) to determine the most effective dose that improves sensory/motor function and cognitive out-
comes, and reduces mortality. For the second aim, the efficacy of CBD to reduce the development of vaso-
spasm and blood-brain barrier leakage will be investigated utilizing intravital microscopy and ex vivo micro-
Computed Tomography imaging. The research proposed in this application is innovative because it proposes
the use of a compound with a wide variety of molecular targets capable of ameliorating multiple aspects of
SAH pathology. The proposed research is significant because it is expected to provide scientific justification
for the continued mechanistic investigation of CBD as a much-needed novel therapeutic for SAH patients,
advancing the field of stroke research.

Public health relevance
NARRATIVE The proposed research is relevant to public health because subarachnoid hemorrhage is a worldwide problem with a high rate of disability and death in working age adults, leading to high costs and loss in productivity. This project is focused on developing cannabidiol as an effective therapeutic for subarachnoid hemorrhage to improve vascular health and functional outcomes. Thus, the proposed research is relevant to the NIH mis- sion to reduce illness and enhance quality of life.